Programming of PMN host-defense function during transendothelial migration

PROJECT SUMMARY / ABSTRACT
Polymorphonuclear neutrophil (PMN or neutrophil) maintain human health by rapidly eliminating the invading
pathogens. These circulating cells transmigrate across the endothelial adherens junctions (AJs) to enter into the
infected tissue and to clear the pathogens. Little is known about the role of mechanical forces which PMN
experience during transmigration across the endothelium. Our Supporting Data describe the potentially
important role of adherens junctions in activating PMN’s host defense function. We observed that activation of
PMN-expressed Piezo1 during paracellular transmutation induced calcium influx, which in turn, promptly
stabilized Hif1α and upregulated expression of NADPH oxidase 4 (Nox4) in PMN to program these cells to
efficient “killers” of the pathogens. These findings have for the first time linked PMN-expressed Piezo1 to the
host-defense function, leading to the fundamental question “how Ca2+ influx in PMN via Piezo1 program the
host-defense function of PMN?” In Aim 1, we will determine the role of PMN-expressed Piezo1 signaling
pathway in activating the host-defense function of transmigrating PMN. Here we will delineate the signaling
pathways downstream of Piezo1 activation that promptly stabilizes Hif1α in PMN and programs PMN to become
more efficient bacterial “killers”. The studies will involve genetic analysis of Piezo1- Hif1α signaling of the
transmigrating PMN such as PMN-specific Piezo1 and Hif1α knockout mice. We will also determine whether
pharmacological activation of Piezo1 or expression of gain-of-function Piezo1 mutant in PMN is sufficient to
activate the PNM defense system in the relevant P. aeruginosa-induced pneumonia model. In Aim 2, we will
determine the role of PMN-expressed Nox4 in regulating oxidative and lytic properties of PMN and in the
efficient elimination of pathogens in lung. These studies will address the function of Nox4 in PMN in the
mechanism of innate immune defense program. Using in vitro and in vivo experiments, we will determine how
Hif1α induces activation of Nox4 gene and how Nox4 regulates oxidative and lytic properties of phagolysosome
and efficient pathogen killing. The proposed studies will be essential for understanding the regulation of PMN
host-defense function with the goal of identifying therapeutic potential of Piezo1 activators.

Public health relevance
NARRATIVE Neutrophils are white blood cells that kill the pathogens in infected tissue. We believe that this antibacterial function of neutrophils is activated by mechanical forces these cells experience as they migrate through vascular endothelial junctional barrier into infected tissue. The research will help us understand how the tension sensed by transmigrating neutrophil “educates” neutrophils to fight with tissue pathogens and hopefully lead to better treatments for patients with bacterial infection.